Stability Study Protocol for 0.1% Estradiol Type A Medicated Article (Estraqua?)

RESEARCH & RELATED Other Project Information:
Section 7 Project Summary/Abstract
This Type A stability project is required by the FDA Center for Veterinary Medicine to
complete a portion of the CMC technical section of the new animal drug application.
This project will evaluate stability of INAD 012-884 (Type A Medicated Article, 0.1%
estradiol (Estraqua®)) under ambient (25 ± 2 °C / 60 ± 5% RH) and accelerated (40 ± 2
°C / 75 ± 5% RH) conditions over several months. Appearance, estradiol level, particle
size distribution and loss upon drying will be evaluated over time. The proposed INAD
will be administered in feed (at a dosing rate of 5 ppm) to American eels (Anguilla
rostrata) in a recirculating aquaculture system (RAS). Information from this stability
study will substantially contribute to full FDA approval.

Public health relevance
Other Project Section 8 Project Narrative – Type A Stability Study for Estraqua Development of estradiol as a veterinary drug for increasing the rate of weight gain in farmed American eels (Anguilla rostrata) could lead to the release of estradiol to the environment. The Type A Stability Study for the INAD, Estraqua, will provide key information on the stability of the drug and will allow for determination of shelf-life recommendations and will substantially contribute to full FDA approval.